Regulation and Function of PlexinA2 Forward Signaling in Persistent Pain

Summary
Persistent pain develops following nerve injury when primary sensory neurons show complex, activity-
dependent plasticity and ectopic discharges. It is often refractory to existing treatments and associated with
adverse health outcomes. The dorsal root ganglion (DRG) is a collection of several types of sensory neuronal
cell bodies and satellite glia which acts as the initial point of modulation of action potentials from potentially
noxious stimuli to second order spinal cord neurons. Epigenetic variability is known to cause dysregulation of
gene transcription which may modulate nociception to alter an individual’s susceptibility for persistent pain.
Chromatin accessibility regulates transcription factor binding to cis-regulatory regions and subsequent changes
in gene expression. Therefore, understanding how changes in chromatin accessibility at these regulatory regions
modulate transcription factor binding in chronic pain states would help to identify regulatory loci in the DRG.
Following peripheral nerve injury, regenerative mechanisms are activated to recover lost motor, sensory, and
autonomic functions. Neuropathic pain develops when these mechanisms promote maladaptive neural
connectivity that becomes electrically hyperexcitable and generates spontaneous and evoked action potentials.
How these processes become activated to promote pain in the absence of nerve injury is unknown.
We have completed the first comprehensive map of changes in chromatin accessibility with matching RNA-
seq in the DRG using two well-studied models of persistent pain – surgical ligation of the sciatic nerve (CCI) and
hind paw inflammation (CFA). We identified differential expression of members of the plexin-semaphorin
pathway with changes in chromatin accessibility at their putative cis-regulatory regions. This pathway generates
attractive or repulsive cues to reunite with its distal, denervated segment. PlexinA2 is a member of a large family
of receptors that bind to semaphorin, which then heterodimerizes with Nrp1 to form a functional neuronal receptor
that activates Rnd1. The role of PlexinA2, Nrp1 and Rnd1 in persistent pain remains unclear. However, altered
Plxna2 expression during development disrupts normal peripheral nervous system morphology. We hypothesize
that altered epigenetic regulation of Plxna2, Nrp1 and Rnd1 expression in sensory neurons plays a functional
role in axon guidance and promotes persistent pain states. In addition, we hypothesize that changes to the
sensory environment during neuronal development may epigenetically prime nociceptors to promote altered
nociceptive thresholds later in life. We will pursue the following Specific Aims to test our hypotheses: (1) To
determine how chromatin topology affects Plxna2 expression and genes involved in its forward signaling in DRG
neurons in neuropathic and inflammatory pain conditions, (2) To understand how modulation of the Plxna2-Nrp1-
Rnd1 axis in DRG neurons alters neurite structure and pain behaviors, (3) To determine the effects of early-life
stress on Plxna2 signaling in the dorsal root ganglion following nerve injury in later life.